Development of a new social media fMRI task to better investigate bidirectional links between social media use and emotional health in youth.

PROJECT SUMMARY/ABSTRACT
There has been much interest in the potential role of social media (SM) use in driving a current mental health
crisis among teens, with a dire need for evidence that goes beyond self-report. One important avenue is to
understand the role of the brain in mediating or moderating the effects of SM use on emotional health and vice
versa. However, there is almost no research addressing these questions, largely due to a lack of fMRI tasks
that can probe the neural correlates of modern SM use. Existing tasks measure neural response to simulated
threat and reward from fictitious peers but are out of date and do a poor job of simulating the SM experience of
today’s youth. We developed a preliminary version of the TeenBrainOnline (TBO) Task, an fMRI task that
mimics key features of SM that are posited to enhance the salience of social feedback, such as quantifiable,
public, and dynamic indicators of peer status. The goal of this project is to further develop and validate this new
developmentally-salient and ecologically-valid task. In Phase 1 (months 1-8), we will program the task for
eyetracking and create stimuli for boys (as we previously only created stimuli for girls) and gender and
racially/ethnically diverse youth to add to the task. We will also use a co-design participatory action approach
with a Youth Research Advisory Board (YRAB) comprised of teens ages 13-17 to add comments to the task,
and to obtain other feedback on potential task improvements. We will then conduct 10 pilot scans, with iterative
improvements to the task based on scan results and YRAB feedback. In Phase 2 (months 9-24), 50 teens
(ages 13-17) with depressive symptoms will complete the final version of TBO during fMRI with eye-tracking,
the older Chatroom Interact (CHAT-I) Task, ecological momentary assessment (EMA) of daily SM use, and
measures of depressive symptoms. In addition to computing split-half reliability, twenty youth will complete the
task again after three months for test-retest reliability. We will evaluate construct validity by testing whether the
task activates brain regions that typically respond to social evaluation (e.g., amygdala, anterior insula, dorsal
and subgenual anterior cingulate cortex, and ventral striatum) and elicits visual attention biases using eye-
tracking. Predictive validity will be assessed by attempting to show that ASN activity and attention biases on
TBO predict variability in depressive symptoms at baseline and three months later, and are more predictive
than similar indices from CHAT-I. Convergent validity will be tested by examining whether TBO neural and
eyetracking indices converge with EMA indices of SM use, focusing on indicators of a social evaluation
orientation toward SM (e.g. social comparison orientation, fear of missing out, digital status-seeking). We
expect that these associations will be stronger for TBO compared to CHAT-I indices. We will also explore
whether ASN activity on the TBO Task interacts with SM experiences to predict symptoms of depression. The
task will be disseminated to facilitate future longitudinal and bidirectional studies of SM use, brain activity, and
emotional health, consistent with the goals of this RFA.

Public health relevance
PROJECT NARRATIVE This project will result in a realistic, developmentally-salient, and ecologically-valid fMRI/eye-tracking task that simulates modern SM use which will be disseminated for use in future studies that will advance understanding of the role of neural sensitivity to social evaluation in mediating or moderating the bidirectional links between SM use and emotional health in teens. This will facilitate prevention and intervention efforts by helping to identify (1) neural characteristics of youth at highest risk for emotional health problems related to SM use, (2) how SM use affects and is affected by the brain, and (3) related neural and attentional targets for intervention, using strategies such as transcranial magnetic stimulation or attention bias modification in the context of SM. Findings on which aspects of SM use are most strongly linked to brain functioning and emotional health may also inform SM practice recommendations for vulnerable youth and related policy.